Developing Asymmetric Gold Redox Catalysis for Challenging Chemical Transformations

Project Summary/Abstract
The proposed project’s goal is to develop organic synthesis methodologies for potential applications in
biochemistry and medicinal science to solve important problems (optimizing API production process and
providing new methods for lead compound preparation etc.), which could ultimately benefit human health.
Previous work by this project’s research team has focused on developing new transition metal catalysts
with applications for challenging chemical transformation to reach an efficient synthesis of diverse
chemicals for medicinal and biological research. Recently, with the employment of strong oxidants or
photoactivation conditions, gold(I) oxidation to gold(III) were realized, despite the intrinsic high oxidation
potential. These discoveries further advanced the field of gold catalysis, adding redox chemistry as an
alternative path into the catalytic cycle. However, major hurdles in the current gold catalytic system exist
that limit its full utility to promote some typical chemical synthesis such as asymmetric transformations in
redox chemistry, accessing vinyl-gold intermediate without rapid protodeauration, and integration of gold p-
acid reactivity with redox chemistry, etc. The proposed project will address these hurdles by developing
new strategies and catalysts and by providing new medicinally important avenues toward structures which
are often difficult to access. The project aim will address two fundamental questions in the gold catalysis:
1) Can asymmetric gold redox catalysis be achieved through chiral ligand control with gold(I) as the resting
state? and 2) Will the integration of multiple gold catalysis reaction modes (p-acid, vinyl-gold and redox
chemistry) be integrated in one cycle to achieve highly efficient transformations with good stereoselectivity.
Our research program will focus on the following four specific directions: 1) developing new oxidation
conditions to achieve gold oxidation for a broader scope of substrates for gold redox catalysis; 2) applying
gold/iron dual catalytic system to access vinyl-gold reactivity for direct C-C and C-X bond construction and
macrocyclic compound synthesis; 3) applying chiral N,P ligand to achieve enantioselective alkene di-
functionalization to provide the key factors that might influence asymmetric gold redox catalysis; and 4)
developing new triazole-based chiral ligands systems to achieve gold(III) asymmetric catalysis for rapid and
stereoselective C-C and C-X bond constructions. The research’s expected outcomes will result in new
strategies and methods for alternative approaches toward biomedically important molecules and new
building blocks as molecular probes or potential therapeutic solution.

Public health relevance
Project Narrative The proposed research aims to establish novel strategies and synthetic approaches to advance and enrich gold catalysis and, more importantly, provide methodologies for biological and medicinal related target, which are otherwise very difficult to acquire due to their scarcity, structural complexity, and high cost. This research will also open new avenues toward collections of structurally novel small molecules that enable the construction of chemical libraries for lead compound identification, optimization processes for health and medicinal related chemical production, initiation of new building blocks as biological probes and novel therapeutics. The strategies and methodologies developed in this research will significantly enrich the toolbox of both synthetic chemists and medicinal chemists.